Feasibility Trial of an Implementation Bundle for the National Emergency Airway Registry for Pediatric Emergency Medicine (NEAR4PEM) Pre-Intubation Checklist

Tracheal intubation (Tl) of critically ill children presenting to the emergency department after trauma is a lifesaving but
challenging procedure. It has been found that about 18% of Tis in the pediatric emergency department (PED) are
performed for trauma indications; between 15-30% of patients undergoing Tl in the PED experience adverse events
and nearly one-third require multiple attempts. Pediatric trauma tracheal intubations (TTls) are particularly challenging
due to lack of patient information, very little time to prepare, and rapid assembly of an ad hoc multidisciplinary team.
There is currently no rigorously implemented checklist available for pediatric trauma tracheal intubations (TTls).
Formed under the umbrella of the National Emergency Airway Registry for Kids (NEAR4KIDS, N4K), the National
Emergency Airway Registry for Pediatric Emergency Medicine (NEAR4PEM, N4P) is a multicenter collaborative and
prospective registry for advanced airway management in the PED. Using the robust infrastructure of N4K, including a
data coordination center, we have developed a growing quality improvement research network, achieved high
compliance for reporting Tl process of care and adverse Tl associated events (TIAEs), and described the landscape
of patients, providers, and outcomes of Tl across 13 diverse PEDs. Additionally, to address the unique challenges of
pediatric TTls, we recently developed a consensus-driven, evidence-based N4P Pre-Intubation Checklist using a
multifaceted, rigorous approach. Recognizing that the use of an intubation checklist in the PED is a change in routine
clinical care for many departments, we are currently creating a NEAR4PEM Intubation Checklist Bundle, which
combines the Checklist with identified optimal implementation strategies and clinical outcomes data feedback.
The objective of this study is to use the Exploration, Preparation, Implementation, Sustainment (EPIS) framework and
Expert Recommendations for Implementing Change (ERIC) strategies to guide our implementation of the N4P PreIntubation
Checklist utilizing the Bundle in a pilot cohort of three pediatric trauma centers. We will use mixed method
analyses, including surveys, video review of a proportion of Tis (including all trauma Tis), and focus groups, to
measure checklist adherence, acceptability, and fidelity, a necessary step prior to a fully powered implementation and
dissemination trial.

Public health relevance
Tracheal intubation (Tl) of critically ill children presenting to the emergency department after trauma, such as motor vehicle collisions, falls, and penetrating injury, is a lifesaving but challenging procedure. Quality improvement efforts using airway management checklists have improved outcomes for children undergoing Tl in pediatric and neonatal intensive care units, but no such checklist has been implemented in the pediatric emergency department setting. This study aims to pilot and refine a set of implementation strategies to implement a novel pre-intubation checklist at a broad range of PEDs, which will be studied further in the future to evaluate its effect on clinical outcomes